Translational studies in humans and mice to test a circuit-level computational model of auditory hallucinations..

Auditory hallucinations (AH) are core symptoms of psychosis for which treatment is often ineffective or poorly
tolerated. A first step towards developing more selective and safer biological interventions is to elucidate AH
mechanisms at a neurobiological circuit level, a level at which AH are currently poorly understood. Here, we
use a novel computational circuit-level model combined with translational experiments in humans and mice to
identify circuit mechanisms underlying AH. Dorsal-striatal dopamine (DA) excess is implicated in AH, and AH
severity correlates with a task behavioral phenotype consisting of increased false alarms (endorsing auditory
sounds that are not present in signal-detection tasks) reported with high confidence. In mice, stimulating DA
release in the dorsal striatum also induces this AH-like phenotype of high-confidence false alarms in a similar
signal-detection task. These findings are consistent with computational models whereby AH result from
exaggerated perceptual prior expectations and suggest a role for their implementation in dorsal striatum.
However, the precise relationships between model-proposed cognitive computations and circuit neurobiology
are unclear. Important gaps include how dorsal-striatal DA and medium spiny neuron activity contribute to
perceptual learning and AH-like percepts, as well as potential additional roles of reward-based processes in
ventral striatum. To address these gaps, we have developed a first-of-its-kind computational corticostriatal
circuit model of AH which recapitulates documented behavioral and neural phenotypes associated with
perceptual and reward tasks, and which additionally generates DA-dependent AH-like false alarms. Informed
by this model, here we will use human data from antipsychotic-free patients with schizophrenia (Aim 1) and
mouse data including a mouse model of genetic risk for schizophrenia (Aim 2), combined with a translational
signal-detection paradigm, to test quantitative predictions from our AH circuit model. Aim 1 (humans) will use
behavior, fMRI and neuromelanin-sensitive MRI to test for distinct contributions of perceptual learning to AH
and their implementation by dorsal-striatal circuits and dopaminergic nigral regions innervating dorsal striatum.
Aim 2 (mice) will use DA sensors, neuronal recordings, and optogenetic stimulation to parse the specific
contributions of dorsal and ventral-striatal DA and medium spiny neurons to perceptual learning and AH-like
false alarms. Exploratory Aim 3 will develop circuit-model extensions incorporating additional circuit elements
(e.g., direct D1 and indirect D2 pathways, cholinergic interneurons) to help further explain circuit mechanisms
of existing D2 and candidate non-D2 antipsychotic drugs. This multidisciplinary project will thus use
translational and computational methods combining the strengths of clinical and preclinical research, and of
theory- and data-driven methods, to advance our knowledge about circuit mechanisms of psychosis. By
outlining circuit-level dopaminergic and non-dopaminergic targets, it will further pave the way for developing
novel treatment approaches with enhanced selectivity and tolerability.

Public health relevance
PROJECT NARRATIVE Hallucinations and other psychotic symptoms of schizophrenia are highly burdensome conditions for patients and society at large, and treatments for these symptoms are often ineffective or poorly tolerated. A necessary first step towards developing more selective biological interventions is to elucidate mechanisms of these symptoms at a neurobiological circuit level. Here, we test the predictions of a computational model of corticostriatal circuitry using translational experiments in humans and mice to clarify the circuit neurobiology of hallucinations.